Imaging immune cell type and behavior in the living retina using adaptive optics

Abstract:
Immune cell response to ocular inflammation is involved in various prevalent retinal diseases that lead to
blindness such as glaucoma, age related macular degeneration, uveitis and diabetic retinopathy. However, the
microscopic and translucent nature of circulating and resident immune cells has made study of such cells challenging in
the living eye. Further complicating matters, immune cells move at fast speeds (centimeters/second) when circulating in
big vessels and glacial pace at micrometers/minute when in tissue. This project will combine a number of innovations that
overcome many of these challenges to study single immune cells in the living eye in their response to inflammation. The
use of adaptive optics scanning light ophthalmoscope (AOSLO) to image mouse retina will provide a noninvasive in vivo
imaging method that can resolve single immune cells and track their behavior through the entire course of inflammation.
With our AOSLO, we have recently demonstrated that phase contrast combined with both fast and time-lapse
videography now enables us to visualize these microscopic immune cells using near infrared light alone and without
fluorescence contrast. Therefore, this project will seek to study immune cell dynamics in two models of inflammation in
the living mouse eye and track the cellular responses to initiation, escalation and resolution. And while the approach is
non-invasive and does not require use of fluorescence, we will combine fluorescence confirmation of specific leukocyte
populations that contribute to the inflammatory response. Our project tackles three synergistic aims to track the dynamic
nature of inflammation using two established models: Model 1) An endotoxin induced uveitis model using
lipopolysaccharide (LPS) injection in vitreous of the eye. This results in an acute, short-term form of inflammation. We will
track the initial escalation of inflammation in the retina by monitoring behavior of tissue resident microglia and systemic
early responder neutrophils. And Model 2) An autoimmune uveitis condition that is induced in a healthy host mouse by
injecting a subpopulation of fluorescent CD4+ T cells that are reactive to interphotoreceptor retinoid binding protein from a
different donor mouse. Here, we will characterize the behavior of these foreign reactive T cells in healthy retina, and their
interaction with the host immune system. In both inflammatory models, we will characterize the initiation, escalation,
infiltration and resolution of immune cells in the retina by longitudinally tracking their behavior from hours to days to
months. Finally, in a third aim, we will also study the changes in blood flow in response to these inflammatory models. For
both endotoxin mediated and autoimmune inflammatory models described above, we will monitor structural and functional
changes in retinal vasculature from the largest arteries and veins to single file flow capillaries to understand the interplay
between blood flow and immune cell arrival into the retina. Already, we have observed that the vascular response is not
homogeneous, and arterioles, venules and capillaries respond in different ways to the inflammatory insult and likely
mediate the location, arrival and type of immune cell passage. Together, the longitudinal monitoring of inflammation and
blood flow will provide new insights to the retinal immune response using innovations in high-resolution ophthalmoscopy.

Public health relevance
Project Narrative: Ocular inflammation plays a significant role in vision loss associated with retinal disorders, yet immune cells that facilitate this response are poorly understood due to limitations in imaging these microscopic cells. Using a collection of innovations in high-resolution imaging, this project will image these cells for the first time using a label-free approach combined with fluorescent cell populations to reveal the types and behaviors of immune cells in the living eye as it responds to inflammation.